Interdisciplinary Nutrition Sciences Symposium: Diet and Chronic Unresolved Inflammation: Implications for Obesity-Associated Complications

Abstract
We will convene the third annual Interdisciplinary Nutrition Sciences Symposium (INSS), entitled “Diet and
Chronic Unresolved Inflammation: Implications for Obesity-Associated Complications.” This conference will
address the critical need to establish rigorous interdisciplinary and translational approaches in the context of diet
and nutrition to effectively prevent and treat chronic inflammation associated with metabolic diseases. Interactive
discussions will enable early career investigators and faculty from populations underrepresented in science to
engage with senior investigators, and for academic and industry scientists to collaborate. These highly valuable
experiences will provide early career investigators and trainees with a foundation upon which they will be able
to contribute to the next generation of successful inflammation and nutrition research. Confirmed and invited
speakers include leading national academic scientists from diverse backgrounds with expertise in inflammation
and translational obesity and nutrition/diet research. The four interactive sessions are organized to facilitate and
encourage integration across disciplines, synthesize knowledge, and generate new ideas in selected areas of
innate/adaptive immunity and inflammation, nutrition (including precision nutrition), and obesity. A major goal of
the conference is to build on the dialogue we began in our successful 2019 and 2021 symposia to develop best
practices for translational science and to generate ideas for proposals and collaborative projects. In addition, we
will feature a networking lunch and a session devoted to academic-industry partnership to encourage discussion
across scientific approaches, seniority, and industry/academia ties. We will also hold an early career lunch and
workshop to allow opportunities for detailed discussions around mentoring and career development. Rigorous
evaluation of the symposium will involve summative assessment activities through online surveys conducted via
the conference website to assess what participants learned, what was effective, and what needs improvement.
An anticipated deliverable of the INSS is a scientific paper geared towards a major immunology or nutrition
journal on how to translate findings from basic and clinical studies toward preventing and improving chronic
unresolved inflammation based on rigorous evidence. We will promote the symposium broadly via the American
Association of Immunologists, Society for Leukocyte Biology, American Society for Nutrition, patient support
groups such as the Obesity Action Coalition, nutrition departments, immunology departments, and Nutrition
Obesity Research Center networks. We anticipate that attendees will span the diverse fields of immunology,
nutrition, physiology, bioinformatics, biochemistry, and more. We anticipate attendance of approximately 100
scientists, based on the success of the two last two symposia and the outstanding leading keynote speakers
who have agreed to attend.

Public health relevance
Project Narrative We propose to convene the third annual Interdisciplinary Nutrition Sciences Symposium (INSS), entitled “Diet and Chronic Unresolved Inflammation: Implications for Obesity-Associated Complications,” to address the critical need to establish rigorous interdisciplinary and translational approaches in the context of diet and nutrition to effectively prevent and treat chronic inflammation associated with metabolic diseases. The goal of the symposium is to generate ideas for proposals and collaborative projects and to develop best practices for mechanistic and translational studies at the crossroads of cutting-edge inflammation and nutrition research.